Influence of Particulate Matter on Fetal Mitochondrial Programming

PROJECT SUMMARY
The distribution of engineered nanomaterials (ENM) in consumer products, manufacturing processes and clinical
diagnostics is rising rapidly, despite our limited understanding of their impacts on human health. ENM exposure
is of particular concern during fetal development and it can influence susceptibility to pathological insults later in
life. Mitochondria play an important role in fetal developmental and they can be impacted by environmental
conditions, which has led to the novel concept of mitochondrial programming. Epigenetic changes are important
determinants of mitochondrial programming, as they influence the organelle's proteomic make-up, which is
responsible for its structure, function and redox balance. Nevertheless, mitochondrial programming in the context
of development is understudied. Our laboratory made the initial observation that maternal ENM inhalation
exposure causes cardiac contractile dysfunction and disruption to mitochondrial bioenergetics in the developing
fetus. These effects were sustained into adulthood. We also reported that maternal ENM inhalation exposure
increases epigenetic methylation of mRNAs in the fetal heart. MRNA methylation occurs primarily to adenosine
leading to N6-methyladenosine (m6A), and to a lesser extent to cytosine, leading to 5-methylcytosine (m5C).
The preliminary data in this grant application suggest that maternal ENM inhalation exposure influences fetal
cardiac mitochondrial programming by enhancing oxidant production and mitochondrial dysfunction, but it is
unclear whether this is mechanistically linked by epigenetic methylation to nuclear genome-encoded
mitochondrial mRNAs and loss of mitochondrial proteins. The proposed studies focus on this gap in knowledge
and they are designed to determine whether maternal ENM inhalation exposure negatively influences
mitochondrial programming in the fetal heart and the susceptibility to future cardiac pathological insult, through
an oxidant driven mechanism. The studies address this specific need, as they will identify mechanisms driving
fetal mitochondrial dysfunction resulting from maternal ENM inhalation exposure as well as the susceptibility to
a secondary cardiac pathological insult that occurs later in life. The central hypothesis being tested is that
maternal ENM inhalation exposure epigenetically reprograms fetal cardiac mitochondria through an oxidant-
driven mechanism that results in enhanced susceptibility to a secondary cardiovascular insult at adulthood. The
objectives of this application are to determine the influence of maternal ENM inhalation exposure and the impact
of enhanced oxidant scavenging on (1) fetal cardiac mitochondrial programming that influence mitochondrial
structure, function and redox balance; (2) fetal cardiac epigenetic methylation of nuclear genome-encoded
mRNAs that encode for mitochondrial proteins; and (3) the susceptibility to a secondary cardiovascular insult at
adulthood. Completion of these studies is expected to provide fundamental mechanistic insight regarding fetal
mitochondrial programming in maternal exposure models and the susceptibility to future cardiac pathologies.

Public health relevance
PROJECT NARRATIVE Nanotechnology has provided important advancements in the area of engineering innovation, however, introduction of engineered nanomaterials in these technologies is not without hazard, and the negative effects on human health, at present, can only be speculated without detailed evaluation of their toxic nature. The proposed experiments are relevant to public health because they will enhance our understanding of the pathogenesis of engineered nanomaterial exposure and aid in the development of biomarkers and prophylactic interventions designed to lessen complications that are associated with engineered nanomaterial exposure. Thus, the proposed research is relevant to the NIH's mission that pertains to the pursuit of fundamental knowledge to extend healthy life and reduce the burden of illness.